CORE--INFORMATICS/DATA MANAGEMENT AND ANALYTICAL SUPPORT

The Informatics/Data Management Core will be responsible for providing computer-based data management tools that facilitate the storage, retrieval, and analysis of the data generated in this research. The system must be accessible to each laboratory participating in the project, and should work as a communications gateway and server. It should have power and memory to quickly process large amounts of data for analytical and simulating statistical analysis. The system will build on the prototype database of FCCC and that being developed by the Human Genome Initiative for management of pedigree data and laboratory reagents and results and will have an analysis component to perform linkage segregation and risk analysis.